Understanding the role of bedrock, settlement patterns, and water quality in human health equity

Project Summary
Neither populations nor health outcomes are spread evenly across the natural environment. Due to historical
patterns of selective land settlement, natural resource extraction, forced migration, and land viability,
marginalized populations are more likely to live on land of poor quality. These patterns impact present-day
population health and health disparities through numerous mechanisms. A key underexplored mechanism linking
land quality to health equity is bedrock lithology—the chemical and physical properties of bedrock—which is
linked to population health through water quality. In this study, we will use an interdisciplinary approach to unravel
the relationship between bedrock lithology, settlement patterns, water quality, and health equity across the state
of Oklahoma. This study innovates by piloting a novel methodology for collecting data on water quality and
human health, while also showcasing a unique interdisciplinary link between geochemical and public health
research. We pursue our research relying upon a conceptual model developed for understanding the role of
bedrock in a socially unjust society and do so through three specific aims:
1) Model the relationship between bedrock lithology, land use, settlement, and the uneven distribution of
health-related water quality issues in Oklahoma.
2) Collect primary geochemical data to understand the relationship between bedrock lithology and filtration
of health-impacting pollutants.
3) Survey households throughout Oklahoma to understand how bedrock lithology is impacting drinking
water quality and human health.
By employing a variety of techniques including secondary analysis of government data, primary geochemical
data collection, and a novel linked social science and household water survey, we will triangulate the relationship
between bedrock lithology, drinking water quality, and human health equity. These results will form the essential
building blocks of a larger proposal for independent R01 funding from the NIH in the future.

Public health relevance
Project Narrative The relationship between natural features of land such as bedrock lithology, water quality, and human health remains poorly understood. This project will not only identify the relationship between bedrock, water quality, and human health, but also identify how bedrock lithology and uneven patterns of human settlement impact health disparities through water quality.